Dual Fatty Acid Amide Hydrolase (FAAH)/Monoacylglycerol lipase (MAGL) Inhibitors for Cannabis Use Disorder (CUD).

OTHER PROJECT INFORMATION – Unit 7 – Project Summary/Abstract
This project addresses the growing need for medications for cannabis use disorder (CUD) which, in the
absence of approved medications, is a major focus of NIDA’s mission. Currently available cannabinergic-based
treatments for CUD include the directly acting CB1 agonists, e.g., Δ9-THC or nabilone, which have been
reported to reduce cannabis withdrawal symptoms in humans supporting the therapeutic utility of agonist-based
medications for management of CUD. However, the use of directly acting CB1 receptor agonists is complicated
by adverse cannabimimetic effects, including erratic pharmacokinetics, unwanted physiological and subjective
effects that overlap with those of smoked marijuana, and considerable dependence liability. An alternate
avenue for developing agonist-based treatments for CUD may lie in drugs that indirectly enhance cannabinergic
activity, e.g., by inhibiting the metabolic enzymes fatty acid amide hydrolase (FAAH) and monoacylglycerol
lipase (MAGL) to increase brain levels of the endocannabinoids N-arachidonoylethanolamine (anandamide,
AEA) or 2-arachidonylglycerol (2-AG), respectively. This view is strengthened by our preliminary findings from
CB1-discrimination studies in monkeys showing that combined inhibition of FAAH and MAGL, but neither action
alone, can produce Δ9-THC-like interoceptive effects. More recently, we identified a second-generation dual
FAAH-MAGL inhibitor MAK2376 with improved druggability profile compared to the parent dual FAAH-MAGL
inhibitor AM4302, i.e., MAK2376 showed greater stability to hepatic microsomes and higher aqueous solubility
relative to AM4302. Encouraged by these findings, we plan to optimize pharmacokinetic and pharmacological
parameters of MAK2376 by designing, synthesizing, and evaluating novel derivatives in vitro and in vivo
assays. Novel high potency ligands will be tested in microsomal stability, aqueous solubility, and
pharmacokinetic assays. Criteria for selecting ligands for in vivo studies include: IC50<10 nM (r/hFAAH), <500
nM (r/hMAGL); varying rFAAH/rMAGL inhibition ratio, (e.g.,1/10, 1/50, 1/100); CB1: Ki >300 nM; microsomal
stability, t1/2 (minutes) >15 (m, r) and >30 (human); aqueous solubility (pH 7.4) >60 ug/m; oral bioavailability
>25% and brain/plasma ratio >50%. Select compounds will be tested in vivo tetrad and CB1 discrimination
assays in rats. Our overarching goal will be to discover improved mixed-action FAAH-MAGL inhibitors that
produce Δ9-THC-like stimulus effects at doses that produce minimal CB1-associated tetrad side-effects (e.g.,
hypothermia/catalepsy). The most promising 2-4 ligands will be advanced to Phase II studies in nonhuman
primates for further optimization. We anticipate that novel mixed-action FAAH-MAGL inhibitors that are
successful in this Phase I and highly translational Phase II studies in nonhuman primates will be ‘lead’
compounds that will be further studied in preclinical and clinical trials as candidate medications for CUD. Our
multidisciplinary team of scientific and business experts is well suited to successfully advance this project to
commercialization phase II.

Public health relevance
OTHER PROJECT INFORMATION – Unit 8 - Project Narrative Dual Fatty Acid Amide Hydrolase (FAAH)/Monoacylglycerol Lipase (MAGL) Inhibitors for Cannabis Use Disorder (CUD). Recent widespread use of marijuana or other cannabis products for medical and recreational purposes has contributed to increasing incidences of cannabis use disorder (CUD) that represents a major threat to public health. Currently, no FDA-approved medications are available for treating CUD, which points to a pressing need for developing new effective candidate medications. This project will address this concern with research to develop and identify novel medications that indirectly enhance cannabinergic activity by concurrently inhibiting enzymes that breakdown endocannabinoids, thereby, increasing their levels in the brain to counter CUD.